Phosphorylation as a site-specific regulatory mechanism of the liquid-liquid phase separation of TDP-43 low complexity domain.

Project Summary
The TAR DNA-binding protein of 43 kDa (TDP-43) is a nucleic-acid binding protein whose fragments have
been detected in pathological amyloid inclusions in the brains of patients with age-related neurodegenerative
disorders, including Alzheimer’s disease, amyotrophic lateral sclerosis, and frontotemporal lobar degeneration.
These fragments contain a region of TDP-43 called the low complexity domain (LCD), which has low amino acid
diversity and a propensity to form amyloid aggregates. The LCD also drives TDP-43 liquid-liquid phase
separation (LLPS), a phenomenon in which the protein self-associates into a reversible, dynamic, droplet-like
phase. LLPS is a physiologic process that mediates several functions of TDP-43, including its involvement in the
cellular stress response, but prolonged LLPS has been shown to promote pathological aggregation,
underscoring the need to understand how this process is regulated in vivo.
Phosphorylation of TDP-43 LCD has been well-documented in Alzheimer’s disease and other age-related
neurodegenerative disorders. Though the role of this modification remains largely unexplored for TDP-43, it does
influence LLPS in similar RNA-binding proteins such as FUS. To determine if LCD phosphorylation can regulate
TDP-43 LLPS, phosphomimetic variants of the LCD with Ser->Asp substitutions at known phosphorylation sites
were prepared. Phase separation of variants was studied using light-scattering and microscopy, and it was found
the phosphomimetic substitutions dramatically modulated LLPS in a site-specific manner. LCD variants with
phosphomimetic substitutions in the α-helical region, a part of the protein involved in protein-protein contacts,
displayed reduced LLPS-propensity; conversely, LCD variants with phosphomimetic substitutions in the C-
terminal region (CTR), which is known to be phosphorylated in disease, displayed enhanced LLPS-propensity.
To elucidate the mechanisms behind this site-specific modulation of LLPS, we propose a three-pronged
approach using nuclear magnetic resonance (NMR) spectroscopy, electron paramagnetic resonance (EPR)
spectroscopy and fluorescence resonance energy transfer (FRET). NMR will be employed to determine local
secondary structure of the phosphomimetic α-helical variant. As the α-helical region is known to be altered by
oligomerization, EPR will be used concurrently to see if the α-helical phosphomimetic substitution changes the
oligomerization behavior of this variant. Preliminary data suggest the CTR variants have higher LLPS-
propensities because of an intermolecular electrostatic interaction created by the phosphomimetic substitution
at the CTR. Our second aim will thus use FRET to verify the presence of this hypothesized intermolecular
interaction and probe which residues contribute to it. Furthermore, fluorescence recovery after photobleaching
(FRAP) will be employed to determine how these phosphomimetic substitutions alter the material properties of
TDP-43 LCD droplets. These approaches will provide mechanistic insights into how phosphorylation may site-
specifically direct TDP-43 LLPS and contribute to neurodegenerative pathologies like Alzheimer’s disease.

Public health relevance
Project Narrative Detection of amyloid TDP-43 aggregates in amyotrophic lateral sclerosis, Alzheimer’s disease, frontotemporal lobar degeneration, and many other age-related neurodegenerative conditions underscores the importance of learning what processes regulate this protein’s behavior and how its dysregulation contributes to pathological development. This proposal seeks to investigate how phosphorylation may modulate TPD-43 phase separation, a process that has been shown to promote pathological TDP-43 deposition. This knowledge will aid in developing a greater understanding of the molecular basis of neurodegenerative diseases involving TDP-43, and could one day provide insights for therapeutic strategies based on the modulation of phase separation or post-translational modifications.